Core A - Administrative/Statistics Core

CORE A – PROJECT SUMMARY/ABSTRACT
Core A. Administrative, Statistics and Bioinformatics Core
Paul F. Lambert, Leader
The Administrative/Statistics (Admin/Stats) core provides two essential elements: oversight of the program
project grant and expertise in statistics and bioinformatics. Oversight occurs at multiple levels, intellectual,
administrative and financial. Intellectual oversight is achieved through multiple levels of interactions by the PI
with Project leaders and their lab members, and with Core leaders. An internal advisory board provides twice
annual assessments of the program and advises Dr. Lambert of its findings. An external scientific board provides
annual assessments of the program and advises Dr. Lambert of its findings. Ms. Mary Jo Markham, a long-time
member of McArdle, assists Dr. Lambert with administrative oversight. She organizes multiple venues described
in the core that facilitates faculty interaction, coordinates the training efforts of each lab, and helps the faculty
adhere to all regulatory and reporting requirements associated with the grant. Mr. Randy Martinson assists Dr.
Lambert with regard to overseeing the financial management of the grant. He has over 35 years’ experience in
coordinating the management of this grant, ensuring that monies are allocated appropriately and used efficiently
to support the 4 projects’ and 3 cores’ needs. Ms. Markham and Mr. Martinson report directly to Dr. Lambert.
The statistics/ bioinformatics sections of this core are led by Drs. Michael Newton (continuing on from the current
funding period to provide primarily biostatistical support) and Huy Dinh (a recent faculty hire with strong expertise
in bioinformatics and extensive training in computational sciences). Dr. Dinh has already collaborated on two
published P01 papers from two different projects (Projects 1 and 4) and is highly engaged in discussions with
other project leaders. Together, Drs. Newton and Dinh provide expertise in the design and statistical analysis of
animal/lab experiments and bioinformatics analyses of genome-wide data sets, respectively, to all projects.
Emeritus Professor, Dr. Norman Drinkwater, will continue to update and advise all projects on use of MSTAT, a
software program he wrote to help scientists in the biological sciences use statistical tests.

Public health relevance
CORE A – PROJECT NARRATIVE In this multi-investigator Program Project Grant (PPG), seven science laboratories at the University of Wisconsin pursue research to understand how viruses cause human cancer and to discover ways to prevent and treat these cancers. The Administrative Core provides two important services to the PPG. First, it provides oversight, as well as administrative and financial support to ensure that the science proposed can be carried out. Second, it provides expertise in statistics and bioinformatics to ensure that conclusions drawn are valid and to discover new insights based upon the analysis of high-dimensional genomics data.